Data Science Training: the Essentials

Project Summary
Federal investments of all types over the last 40 years in the battle against the pathological
consequences of HIV-1 have given hope that a cure will soon be realized. However, those
currently living and aging with HIV continue to present with debilitating health impacts that
negatively affect quality of life. In the context of the neurological complications, people with HIV-
1 can also suffer from cardiovascular, pulmonary, bone and kidney disease revealing that multiple
body systems continue to be impacted despite anti-retroviral therapy successful in preventing
transmission. Harnessing Big Data available through longstanding resources like the National
Center for Biotechnology Information (NCBI), and newer sources including the NIH All of Us
Initiative will increasingly be more widely included and used for testing of critical hypotheses,
many which emerge from laboratory-based research. As discussed in the recent NIH report on
the strategic plan for data science, the rapid technological advances and collection of vast
amounts of genomic and gene expression and other types of biologic data, it has been long
recognized that for biomedical researchers knowledge about varied databanks/repositories, and
expertise in the proper handling, analysis, storage, sharing, and reporting of findings in ways that
are rigorous and disseminate new knowledge, will be important to improve human health and
well-being in a more rapid fashion. In this regard, we recently assembled a workgroup made of
faculty in the neurological sciences to discuss how to strengthen training in computational
sciences for predoctoral and doctoral trainees. One of the findings that emerged from the
discussion was, given the varying degrees of prior preparation/exposure there is disparity in
trainees’ ability to explore more advanced concepts in computational neuroscience and little
instruction on how to apply the tools to scientific investigations of behavior. For our currently
funded R25, we introduced predoctoral trainees to computational neuroscience through lectures.
In the proposed supplement we would provide a deeper immersion through four inter-related
course modules delivered through a combination of in-person and virtual modalities that
maximizes the 10-week summer training period.

Public health relevance
Project Narrative A highly trained diverse biomedical workforce skilled in the essentials of handling and harnessing of Big Data in an ethical fashion is critically important in ushering in the next discoveries of the 21st century. For our currently funded R25, we introduced predoctoral trainees to computational neuroscience through lectures. In the proposed supplement we will provide a deeper immersion for trainees through four inter-related course modules delivered using a combination of in-person and virtual modalities that maximizes the 10-week summer training period.